IL-10NanoCap® for Therapy of Familial Adenomatous Polyposis

Abstract
This SBIR Phase IIb proposal builds on the success of our Fast-track award supporting the pre-clinical
development of FAPXIL, an oral sustained-release micro-particulate formulation of Interleukin-10 for the
treatment of Familial Adenomatous Polyposis (FAP). The Phase I portion of our Fast-track project provided
validation of our large-batch methods and activity in a clinically-relevant murine model of human FAP. The
Phase II segment further optimized the treatment protocol, defined the long-term therapeutic potential and
assessed potential effects of long-term treatment on local and systemic immune homeostasis. Additional Phase
II tasks included production of multiple scale-up batches for validation of batch-to-batch consistency, long-term
stability analysis, transfer of manufacturing methods to a CMO with GMP capability, and a Type C pre-IND
meeting with the FDA to inform future toxicology. Agency recommendations and responses to our interrogatives
form the Aims of this Phase IIb application to continue the development of FAPXIL® towards clinical trials in FAP
patients. To this end, Aim 1 will continue pharmaceutical quality and development activities; Aim 2 will establish
safety, tolerability and pK of FAPXIL in non-human primates; Aim 3 will complete a Type B pre-IND meeting with
the US FDA; Aim 4 will assess Investigational New Drug (IND) readiness and submit an orphan-drug designation
request for FAPXIL. The Aims proposed above will enable Therapyx, Inc. to continue pre-clinical work required
to obtain IND approval for this first-in-class oral biologic. Subsequent production of clinical grade drug product
and IND submission will be supported via NIH's SBIR Commercialization Readiness Program and Company
funds.

Public health relevance
NARRATIVE-PUBLIC HEALTH RELEVANCE Familial Adenomatous Polyposis (FAP) is an incurable autosomal dominant genetic disease afflicting some 50,000 Americans. Hundreds to thousands of adenomas develop in the rectum and colon, forcing colectomy usually in the second decade of life, to avoid colorectal cancer. This Phase IIb proposal seeks to further the development of an oral formulation of the key regulatory cytokine interleukin-10 (IL-10NanoCap®) as a novel therapy for FAP than can safely, sustainable and conveniently deliver this potent immune signal directly to the gut.